HYPOXEMIA AND PULMONARY HYPERTENSION IN GAUCHER DISEASE

The investigators seek to understand the spectrum and severity of pulmonary abnormalities in patients with Gaucher disease and to see if these abnormalities change over time with enzyme replacement therapy.